Core C: Research Experience and Training Coordination Core (RETCC)

CORE C: RESEARCH EXPERIENCE AND TRAINING COORDINATION CORE PROJECT SUMMARY
The Research Experience and Training Coordination Core (RETCC) will harness the resources of both
Baylor College of Medicine and Rice University, both outstanding research institutions that have a solid history
of training successful scientists and engineers. These institutions have a long history of academic cooperation,
along with the other Texas Medical Center institutions, including the University of Texas Medical Branch at
Galveston (UTMB) and M.D. Anderson Cancer Center, the Baylor-Rice Superfund Research Program (SRP) will
provide a unique opportunity to create a new and highly innovative training program within the largest medical
center in the world focused specifically on scientific and medical research related to environmental impacts of
Superfund sites.. The purpose of the RETCC core is to create a cross-disciplinary training environment and
mentorship program to help develop next-generation scientists and engineers to tackle complex environmental
health and biomedical science challenges relevant to Superfund-oriented research. This RETCC will leverage
the emerging resources in the Texas Medical Center relating to environmental health and science, including the
newly established T32 Training in Precision Environmental Health Sciences (TPEHS), a joint initiative between
Baylor College of Medicine and University of Texas Health Science Center – Houston School of Public Health.
This SRP will focus on detecting and assessing the effect of maternal polycyclic aromatic hydrocarbon exposure
on fetal and childhood health and health impacts of potential remediation strategies. The Research Projects
encompassed in this SRP will expose trainees to innovative approaches, state-of-the-art technologies, and
established investigators/mentors to accomplish hypothesis-driven research and importantly, use their findings
to bring about lasting change to communities and Superfund stakeholders.